Bridges to the Baccalaureate at Florida A&M University

Enter the text here that is the new abstract information for your application.
As Florida’s second Morrill Act land grant institution, Florida A&M University (FAMU) has a rich tradition in cultivating students from all backgrounds with superior academic qualities. Despite efforts at all state universities, the dearth of doctoral degrees in the sciences remains a problem. This is in part due to underutilization of public Community and State Colleges. The Bridges to the Baccalaureate (B2B) Research Training Program at FAMU aims to provide structured, evidence-based activities to prepare a varied cohort of community college students to transfer to and complete a bachelor's degree in biomedical research fields; stimulate interest among students across the campuses of TSC and FAMU to pursue biomedical research-based terminal degrees; and increase the number of students who are prepared to pursue leadership positions in STEM research enterprises. Through an intricately designed program interwoven with social cognitive career theory and community cultural wealth, B2B acknowledges and leverages students’ cultural capital, backgrounds and experiences, and their impact on self-efficacy, science identity, career decision making, everyday actions, and outcomes. The B2B will recruit and maintain 4 B2B trainees in years 1 through 5 with a minimum 2.7 GPA, full-time enrollment in the gateway science courses, and strong research career interest; establish a semi-structured Peer Mentoring program where Year II B2B trainees are matched with FAMU NCI CaRE2 trainees, and YEAR I B2B trainees to facilitate topic based and informal mentoring; and facilitate professional development of TSC faculty and academic advisors to better align advisement with preparation for matriculation into biomedically-related baccalaureate programs at FAMU. The B2B will provide faculty-mentored research experiences where B2B trainees produce mini proposals for projects that serve as the basis for mentored research training and use results from their authentic research experiences to present at regional symposia and national science conferences. Career development activities, including academic success workshops, professional development seminars, research seminars, structured and independent activities related to career exploration in the biomedical sciences, and leadership development trainings will enhance the institutional culture of both TSC and FAMU. This partnership will be further leveraged to implement an Annual Research Day at TSC that features presentations from B2B trainees and other students involved in research at TSC and FAMU. Open to the broader TSC and FAMU campus communities, Research Day will help facilitate learning about biomedical research related careers and training opportunities.

Public health relevance
To recruit, train, and graduate a talented and motivated group of undergraduate students, who are highly competitive in biomedical sciences careers and who will expand the workforce and help to eliminate health differences among the population.